Evaluation of the Electronic Cigarette Withdrawal Syndrome: Mechanistic Targets for Intervention

PROJECT SUMMARY ABSTRACT
Electronic cigarettes (e-cigarettes) are among the most important issues in public health today. Although e-
cigarettes have shown promise as a cessation aid for traditional cigarettes, the public health benefits of these
products may be undermined by the soaring rates of initiation among previously nicotine-naïve youth and the
propensity for these products to foster nicotine dependence. There are a growing number of people who report
wanting to quit using e-cigarettes and not being able to do so successfully, underscoring the need for research
to determine factors that impede e-cigarette cessation. When smokers abstain abruptly from combustible
cigarette use, a withdrawal syndrome emerges that includes core symptoms of negative affect and craving,
impaired cognitive functioning, and disturbed sleep, all of which ultimately hinder cessation attempts. However,
there is very limited controlled research on e-cigarette withdrawal, and it is unknown the extent to which nicotine
contributes to any emergent e-cigarette withdrawal syndrome. This project will use a rigorous residential
laboratory design to evaluate e-cigarette withdrawal expression and experimentally determine the role of nicotine
in this syndrome. Healthy adults who exclusively use e-cigarettes (N=120) will undergo monitored e-cigarette
abstinence over seven days (1 week) in a residential unit. We will evaluate the contribution of nicotine to
withdrawal expression by assigning participants to one of three conditions: active nicotine patch, placebo patch
control, or no patch to control for expectancies. Standardized behavioral and biological measures associated
with withdrawal including patient report, cognitive task performance, and biometrics will be collected throughout
to establish a rigorous timecourse of withdrawal and evaluate the contribution of nicotine to these symptoms.
Three Specific Aims are designed to test core features of nicotine withdrawal mirroring three core areas of
nicotine/tobacco withdrawal described in the DSM-5. Specific Aims will evaluate the timecourse and contribution
of nicotine to withdrawal-induced changes in subjective mood (Specific Aim 1), cognitive performance (Specific
Aim 2), and sleep disturbance (Specific Aim 3). An Exploratory Aim will evaluate the impact of withdrawal on
motivation and return to use. We hypothesize negative affect and craving will increase, cognitive performance
will decrease, and sleep will be impaired during the residential abstinence period. We also hypothesize that
withdrawal symptoms will be attenuated with nicotine patch relative to both control conditions. This research will
use a rigorously-controlled residential study to provide vital information about the clinical significance of
behavioral and biological e-cigarette withdrawal symptoms and demonstrate the role of nicotine in the expression
of withdrawal to inform the viability of translating established and readily accessible nicotine replacement
interventions to e-cigarette cessation.

Public health relevance
NARRATIVE Electronic cigarettes (e-cigarettes) are one of the most widely used tobacco products and a growing number of people report wanting to quit using them, yet little is known about e-cigarette withdrawal and there are no proven interventions for promoting e-cigarette cessation. The goal of this project is to rigorously evaluate the nature of e-cigarette withdrawal in exclusive e-cigarette users during a monitored abstinence period and the role of nicotine in the expression of this withdrawal syndrome. The proposed project will provide essential information to the FDA and public health organizations about the clinical significance of behavioral and biological withdrawal outcomes and inform mechanisms for e-cigarette cessation.